Mechanisms and Functions of ATR signaling

Project Summary
The premise of this application is that discovering the basic mechanisms and functions of replication stress
signaling pathways will contribute to the development of effective cancer therapies. Specifically, our goal is to
understand how the ATR (ATM and rad3-related) kinase promotes genome stability and how its inhibition could
be useful as a cancer therapy. ATR functions at the apex of DNA damage and replication stress response
pathways that are needed every cell division cycle to promote the complete and accurate duplication of the
genome. Many cancer cells are highly dependent on ATR function for proliferation and viability because of
elevated levels of oncogene-induced replication stress and mutations in other genome maintenance pathways.
Inhibiting ATR hypersensitizes cells to DNA damaging chemotherapies and targeted agents like PARP
inhibitors. Thus, ATR may be a useful drug target and ATR inhibitors are currently in clinical trials in a variety of
cancer settings. We previously defined how ATR is activated, identified critical targets to control DNA
replication and cell division, and defined synthetic lethal opportunities where ATR inhibitors could be useful. In
this proposal we will extend these studies to examine specific mechanisms of ATR action that promote the
survival of cancer cells. We will define mechanisms for how ATR regulates DNA damage tolerance pathways,
use unbiased approaches to expand our understanding of ATR-dependent regulation of replication stress
responses, and study the unique functions of individual ATR activating proteins including ETAA1. This is a
focused proposal aimed at understanding the most important and least understood aspects of ATR function.
Specific hypotheses and innovative concepts based on preliminary data are tested using advanced
biochemical and genetic approaches. In addition, the aims provide opportunities for unexpected discoveries
about the mechanisms that maintain genome integrity and the mechanisms of action of ATR pathway
inhibitors.

Public health relevance
Project Narrative/Relevance The ATR kinase is a master regulator of replication stress and DNA damage responses. ATR signaling inhibitors are currently being developed as anti-cancer agents. By defining mechanisms by which ATR functions and identifying cellular consequences of inhibiting ATR, this project will assist the development of ATR pathway inhibitors as effective cancer therapies.